Blood Protein Markers of Biologic Treatment Response in Crohn's Disease

Project Summary
Crohn’s disease (CD) is a chronic inflammatory condition of the gastrointestinal tract often complicated by
intestinal fistulas and strictures that can result in irreversible bowel damage. Anti-tumor necrosis factor alpha
(anti-TNF) biologics are efficacious in treating CD but many patients do not respond to anti-TNF therapy. The
armamentarium for CD is rapidly increasing with new therapies that target novel pathways, such as anti-
interleukin 12/23 (anti-IL12/23) agents. There is an urgent need to develop precision medicine approaches for
selecting the right treatment for the individual CD patient. Our group has identified a novel cellular module in ileal
surgical resection tissue from severe CD patients called the IgG plasma cells, Inflammatory Mononuclear
phagocytes, Activated T cells, and Stromal cells (GIMATS) module. We have demonstrated that treatment naïve
patients with high GIMATS enrichment in ileal biopsies are significantly more likely to fail anti-TNF therapy.
However, tissue-based biomarkers are less scalable for clinical application, while blood-based markers will be
more easily implemented and validated. More recently, in work as part of my K23, we demonstrated that a panel
of peripheral blood proteins assayed at time of diagnosis in CD patients can predict anti-TNF treatment response.
This blood protein panel performed similarly in two independent cohorts and could distinguish anti-TNF
responders better than clinical features alone. We aim to build upon this prior work by expanding the number of
proteins assayed as potential biomarkers of anti-TNF response. We hypothesize that the performance of our
anti-TNF blood protein panel will improve through the addition of markers selected from a discovery panel
enriched for proteins highly expressed in cell types associated with anti-TNF resistance (GIMATS module). In
Aim 1, we propose to evaluate the association of an expanded panel of blood proteomic markers with anti-TNF
response in anti-TNF treated CD patients from the Risk Stratification and Identification of Immunogenetic and
Microbial Markers of Rapid Disease Progression in Children with Crohn’s Disease (RISK) and the Ocean State
Crohn’s Colitis Area Registry (OSCCAR) cohorts. In Aim 2, we will then explore the association of blood
proteomic markers with anti-IL12/23 response, including understanding the drug specificity of anti-TNF response
protein panels, in two prospective cohorts of CD patients treated with anti-IL12/23 therapy. In both aims, we will
utilize a highly sensitive, robust, replicable proteomics assay that is sample sparing with high potential for
scalability. Data generated through this R03 award will serve as a foundation for future R01 applications by
expanding our proteomic discovery efforts, improving the performance of blood protein panels of anti-TNF
response, and exploring blood markers of response to a new class of biologic (anti-IL12/23 therapy).

Public health relevance
Project Narrative Crohn’s disease (CD) is a chronic, progressive disease that can cause irreversible bowel damage with complications including strictures, fistulae and bowel resections. As the armamentarium of therapeutic agents for CD continues to expand, there is an increasing need for precision medicine approaches in treatment selection. In this grant, we aim to expand and improve the performance of a set of blood proteins that can predict anti-tumor necrosis factor alpha (anti-TNF) treatment response and then to explore blood biomarkers of response to a newer drug class used to treat CD, anti-interleukin 12/23 (anti-IL12/23).